Developmental Research Program

PROJECT SUMMARY/ABSTRACT – DRP
The goals of the Developmental Research Program (DRP) of the MSK Pancreas SPORE are to expand the
breadth of the translational pancreatic cancer research base and to encourage highly innovative investigations
that have major potential to impact pancreatic cancer outcomes. DRP funds, supplemented by institutional funds,
will allow us to support 2 exceptional pilot projects each year. We will request proposals for pilot projects with a
clear translational focus and with potential to ultimately impact clinical care of patients with pancreatic
neoplasms. Investigators (MD, MD/PhD, DO, or PhD) with a demonstrated history of pancreas cancer research
appointed at MSK or a neighboring institution, Weill Cornell Medical College and the Rockefeller University, will
be eligible to apply. Applications will be peer-reviewed by the CEP/DRP Selection Committee, which is
composed of the SPORE PIs, DRP and CEP Leaders, select MSK Departmental and Divisional Chairs, and
representatives from the MSK Equality, Diversity & Inclusion Council. The most meritorious projects based on
defined review criteria will be selected. Preference will be given to projects that advance the long-term research
goals of the SPORE and have high potential to become full SPORE projects. We will prioritize projects submitted
by early-stage investigators and are committed to promoting diversity and strengthening the participation of
women and underrepresented groups in translational research. DRP awardees will have full access to SPORE
Core resources, will benefit from the expertise of the SPORE investigative team, and will be active participants
in the SPORE. The scientific progress of DRP projects will be evaluated every six months by the DRP Leaders.
Long-term metrics of success for DRP awardees include presentation/publication of original research, successful
competition for independent research support, successful development and completion of clinical trials stemming
from DRP research, establishment of new collaborations, and institutional recognition by academic
promotion. DRP projects that make significant progress towards their translational goals will be eligible for a
second year of funding and have the potential to be promoted to full SPORE projects.

Public health relevance
NARRATIVE Not applicable.